1/2 Partnerships to Enhance Alcohol Research across NCCU and UNC (PEAR-NC)

This is an application for a cooperative agreement (U54), “Partnerships to Enhance Alcohol Research across
NCCU and UNC (PEAR-NC),” between faculties of North Carolina Central University (NCCU), a Historically
Black College or University, and the Bowles Center for Alcohol Studies (BCAS) at the University of North
Carolina (UNC) School of Medicine. This proposal represents a true collaborative effort between the NCCU
and UNC faculty with both groups contributing significant effort and being essential to the success of this
Alcohol and Health Disparities program. Within this proposal, an NCCU Administrative Core and three
Research Components will integrate with the UNC-BCAS Administrative Research Components, as well as
other activities at the Bowles Center for Alcohol Studies. The UNC NIAAA Alcohol Research Center (ARC) and
BCAS have many faculty studying mechanisms of alcohol pathology across the spectrum of behavioral, tissue,
and cellular pathologies that occur with alcohol exposure. This proposal will focus on cellular pathologies that
allow collaborative research partnerships on common areas of interest between UNC and NCCU faculty.
These partnerships open UNC research laboratories, core facilities, and medical libraries to NCCU faculty,
improving opportunities for developing productive research laboratories at NCCU. In addition, due to recent
NCCU NIAAA R awards, large numbers of NCCU students will continue to become involved in research on
mechanisms of alcohol pathology, providing education on African American alcohol-related health disparities
which are due to increased morbidity to alcohol-related pathologies and not increased alcohol use disorder.
The objective of this U54 partnership is to investigate molecular mechanisms of alcohol-induced cellular
pathology. This proposal includes three NCCU research projects, involving six NCCU faculty, that will
investigate the molecular mechanisms of fetal alcohol pathology, alcohol-induced mammary stem cell toxicity,
and neuroimmune responses in adolescent and adult brain. A second objective is to provide research
experiences and scholarly education on alcohol pathology for NCCU students. The educational efforts in this
proposal will involve NCCU undergraduate and graduate students through the BCAS seminar series, through
training in UNC laboratories and research development and mentor meetings, attendance and presentation of
data at the annual RSA meeting, an alcohol seminar series hosted by NCCU, new course curricula on alcohol
pathology developed with a focus on health disparities, as well as specific undergraduate student summer
internships for NCCU students to study and learn about alcohol pathology and health disparities within
laboratories in both institutions. Ultimately, this proposal will conduct, promote, support, and mentor research
into mechanisms of alcohol pathology, creating an active and successful alcohol research program within
NCCU that synergizes with UNC to advance education and discoveries.

Public health relevance
This proposed U54 Collaborative Partnership between NCCU and UNC involves increasing NCCU alcohol research and student research experiences in fetal alcohol toxicity, alcohol neurotoxicity, and alcohol-induced carcinogenesis and inflammation. Health disparities include increased severity of alcohol-related pathology. Collaborative partnerships that carry out integrated and focused research on the molecular mechanisms of alcohol pathology involving faculty and students from NCCU, a historically Black College or University, educate and involve future researchers on alcohol-related health disparities and provide opportunities for careers in medical fields as well as making discoveries on mechanisms that may lead to cures.